PLASMA AMINO ACID CONCENTRATION AND NITROGEN BALANCE IN PRE-TERM INFANTS

The primary objectives of this study are to compare amino acid concentrations, indices of liver function and growth parameters in children who are receiving TPN formulated with either TrophAmine(r) or a standard amino acid solution FreeAmine III(r).